EFFECTS OF ELEVATED FATTY ACID ON INSULIN SECRETION &MUSCLE GLUCOSE

Investigate the effects of elevated non-esterified fatty acid (NEFA) levels on basal and glucose-stimulated insulin secretion in normal subjects. Test the hypothesis that increased NEFA levels lead to impaired insulin stimulated muscle glucose utilization and investigate whether this might be related to an enhancement of muscle glycogen stores.